Synaptic Transmission in The Rod Pathway of the Mammalian Retina

Project Summary: The broad goal of this proposal is to understand how neurons are organized into circuits
and how neural circuit function arises from the intrinsic properties of component cells and synapses. The
mouse retina serves as the model system because of its well-understood organization and function and
because mouse models offer powerful genetics-based tools. Our goal is to understand how synaptic
inhibition by amacrine cells (ACs) generates the functional diversity of retinal output channels: i.e., the
unique responses of individual ganglion cell (GC; the retinal output neuron) types to a visual stimulus. This
objective is related to broader studies that have highlighted the morphological, genetic, and functional
diversity of inhibitory neurons in the retina and elsewhere in the central nervous system.
Our focus will be on synaptic inhibition of the best-characterized GCs in the mouse retina: the “alpha”
GCs, which include the ON α GC, the OFF α GC, and the OFF δ GC. Primarily, we will examine circuits
presynaptic to the OFF δ GC to determine how different genetically-identified AC types act to shape the
OFF δ GC receptive field. Very broadly, a visual stimulus that depolarizes an inhibitory AC strongly will
suppress a postsynaptic GC: thus, AC activity may serve to suppress GC responses to particular regions of
stimulus space (e.g. high spatial frequencies), thereby enhancing the response to other regions of stimulus
space (e.g. low spatial frequencies). To describe the component of retinal computation encoded by the
output of a single AC, the response of that AC to visual stimuli must be understood and the dynamics of
transmission from its synapses assayed. Knowing both the connectivity of the AC, the features of the visual
scene that depolarize it, and the behavior of its output synapses will provide insight into its circuit function.
We therefore will combine ultrastructural and electrophysiological assays to understand how different AC
types act to shape GC outputs.
Relevance to Public Health: Understanding how visual stimulus coding is implemented by retinal
synapses informs the design of retinal prosthetics and the study of animal models of human retinal
diseases. The proposed work clarifies how visual signal processing is modulated at three stages in the
retinal network and addresses two goals of the Retinal Diseases Program in the National Plan for Eye and
Vision Research: one, it builds on knowledge gained from retinal neuroscience to understand how retinal
networks process visual images, and two, it works toward identifying the post-photoreceptor neural
components of adaptation.

Public health relevance
Relevance: The proposed studies concerning the mechanisms governing visual stimulus coding by synaptic interactions in the mammalian retina will generate fundamental information about the neural basis of vision. This will facilitate the evaluation of retinal circuits in mouse models of human retinal diseases and the assessment of treatment strategies in these models. Additionally, our proposed and novel studies using genetically-encoded markers for electron-microscopic analysis of the mammalian retina will expand the utility of existing datasets and imaging methodologies.